Altered arterial smooth muscle in cerebrovascular dysfunction during aging: remodeling of adhesion molecules

Cerebral small vessel disease (CSVD) could be caused by resistance artery narrowing, small cerebral artery
embolism, capillary rarefaction and other etiologies. The prevalence of CSVD increases significantly with aging,
and accounts for 25% of ischemic stroke and 45% of dementia, with hypertension being the preeminent risk
factor. Mechanistically, an exaggerated myogenic response (vasoconstriction to increased pressure) and
endothelial dysfunction are major causes of excessive resistance artery narrowing. Our preliminary data on rat
supracerebellar artery (SCA) suggested that under steady-state myogenic vessel tone, the phosphorylated
myosin light chain (pMLC) polarized to the outer layer smooth muscle cells (VSMC). This novel observation
suggested a previously unknown signaling mechanism that drives MLC phosphorylation predominantly in the
outer VSMC layers of the vessel wall, which subsequently maintains the SCA myogenic tone. Cell adhesion
molecules, both integrin α5β1 and N-cadherin, are capable of mediating mechanical force-induced VSMC
contraction. Preliminary data has suggested that, similar to pMLC, the clustering of N-cadherin peaked in the
outer layer VSMC of SCA, and its expression increases in SCAs of spontaneous hypertensive rats, while
increased integrin α5β1 expression was also reported in experimental hypertension. These results lead us to
hypothesize that the transmural MLC phosphorylation gradient is at least in-part regulated by vessel wall tension
through integrin α5β1− and N-cadherin-mediated mechanotransduction, and augmentation of these molecules
inappropriately increases cerebral artery myogenic tone during aging combined with experimental hypertension.
As a corollary, alterations in cellular adhesion and remodeling may contribute to cerebrovascular dysfunction
and ultimately sequelae such as a decline in cognitive function. We will compare between young and aged
groups of a genetic hypertensive rat model (SHR vs. WKY). A multi-level experimental approach will be employed,
using pressurized blood vessels and isolated VSMCs along with confocal/super-resolution microscopy,
immunofluorescence, and atomic force microscopy (AFM), to test these specific aims: Aim1: Demonstrate that
comorbid aging and hypertension increases the recruitment of integrin α5β1 and N-cadherin to the outer VSMC
layers in cerebral arteries; Aim2: Demonstrate that VSMCs isolated from aged and hypertensive animal show
increased mechanically-activated contractile signaling mediated through integrin α5β1 and N-cadherin; and
Aim3: Determine the effects of inhibiting integrin α5β1 and N-cadherin on the cognitive function of aged and
hypertensive animals. These studies will establish the basic biology of cellular remodeling involved in the
maintenance of myogenic tone in cerebral small arteries in association with aging and hypertension, and will
potentially provide targets for the development of novel therapeutic approaches directed at reducing excessive
cerebral vessel myogenic responsiveness.

Public health relevance
Cerebral small vessel disease (CSVD) causes cognitive impairment in the aging population, leading to deterioration in the quality of life and increased morbidity, but still has no effective treatments. The proposed study will explore a novel mechanism that alterations in cellular adhesion and remodeling contribute to the maintenance of excessive cerebral small artery myogenic constriction, and could potentially lead to discovery of novel therapeutic targets for CSVD treatments.